Dissecting Orchestrated Immune Responses to Glioblastoma within the Native Tissue Microenvironment to Improve Treatment Outcomes

Project Summary
The interpatient and intratumoral cellular heterogeneity of glioblastoma (GBM) is a major driver of up front therapy
resistance and responsible for GBM’s brief median survival (~15 months). We and others have discovered that
the transcriptomes of neoplastic GBM cells is heavily influenced by their anatomical localization. This led us to
hypothesize that neoplastic and immune cellular composition and function is directly linked to their location within
the tumor microenvironment (TME). Although recent single-cell RNA-sequencing (scRNAseq) studies have
provided broad characterization of the cellular makeup and evolution of GBM tumor cells, dissecting the diversity,
function and regional localization of the neoplastic and immune composition of GBM remains incomplete. There
is also an unfortunate lack of knowledge on the evolution of intratumoral neoplastic and immune cells during GBM
progression, and throughout treatment with standard of care therapy that is composed of ionizing radiation,
temozolomide and dexamethasone. Therefore, a mechanistic understanding of the effects of standard of care
therapy on immune and neoplastic cell population dynamics in pre-clinical mouse models of GBM in combination
with analysis of archival human patient GBM samples will yield transformative advancements in the field. In this
proposal, we will leverage archival patient samples and mouse models of GBM to uncover SOC-related cellular
and molecular evolutionary changes using single cell spatial transcriptomics and proteomics. By integrating
detailed spatial mouse and human data with high granularity, we will identify tumor microenvironment areas of
unrecognized therapeutic vulnerabilities and pave the way for the development of new treatment approaches.

Public health relevance
Project Narrative Malignant gliomas, including glioblastoma (GBM), are a group of lethal brain cancers for which we currently have no effective treatment available because of their high level of heterogeneity and the presence of a highly ineffective immune cell composition, the latter being uncharacterized especially during radiation and chemotherapy treatment. We will use advanced, state of the art single cell spatial transcriptomics and proteomics technologies to determine the spatial localization and activation status of the immune cells of GBM in patient samples and in mouse models that recapitulate features of human GBM before, during and after treating the animals with the same standard of care that patients receive. This research will uncover new information on how tumor cells and immune cells react to radiation and chemotherapy and interact with each other, which we will leverage to design new treatment modalities.